Using Chemical Synthetic Lethality to Identify New Antimicrobial Targets in Gram-Negative Bacterial Pathogens

Project Summary & Abstract
Infectious disease is one of the most pressing health challenges of the new century. The
emergence of multidrug-resistant pathogens is on the rise and new methodologies and molecular
targets are needed for the development of antimicrobial agents. In this proposal, we will address
both shortcomings by implementing an approach that identifies new molecular targets through
the use of drug combination therapies against two difficult-to-treat Gram-negative pathogens,
Burkholderia pseudomallei and Pseudomonas aeruginosa. Our approach is based on chemical
synthetic lethality, a phenomenon whereby two molecules are innocuous individually but deadly
in combination. The selection of the appropriate combination of molecules is based on the effects
of subinhibitory doses of antibiotics, which do not exert growth defects, but can expose genetic
and/or metabolic vulnerabilities that are then exploited by a second inhibitor. We have
demonstrated proof-of-concept for this method and identified a new target in B. pseudomallei with
additional ones to be validated as part of our proposed research.
In the first Aim, we will identify a small molecule inhibitor of methionine synthase, one of the
recently identified targets, which is essential in the presence of low-dose trimethoprim. Validating
the chemical synthetic lethality of this inhibitor in conjunction with low-dose trimethoprim through
cellular assays will yield an antimicrobial cocktail against B. pseudomallei. In the second Aim, the
strategy will be applied to the notorious ESKAPE pathogen P. aeruginosa. Here we will establish
both forward chemical genetics and forward classical genetics screens in the presence of low-
dose antibiotics to find new chemical synthetic lethal combinations as well as novel antimicrobial
targets. This approach will thus facilitate the discovery of a drug cocktail against P. aeruginosa.
With our proof-of-concept in hand and well-defined projects goals, we are poised to successfully
complete the two independent yet related Aims of this proposal in the planned two-year period.
The results will add new antimicrobial targets to the existing repertoire and advance drug
combination therapies against two recalcitrant pathogens.

Public health relevance
Project Narrative Infectious disease is one of the most important health challenges of the new century and new methods are needed to develop antibiotics against emerging multidrug-resistant pathogens. In this proposal, we will leverage a novel approach for identifying drug combinations that inhibit new molecular targets in the recalcitrant infectious agent Burkholderia pseudomallei and the notorious ESKAPE pathogen Pseudomonas aeruginosa. Successful completion of this work will add new molecular targets for discovery of antimicrobial agents, while at the same time introducing effective drug combinations against difficult-to-treat pathogens for further development.